Institutional Career Development Core

The Institutional Career Development (KL2) core proposes an innovative, flexible program to prepare a cadre
of experts in clinical and translational (C/T) research to address the lack of optimal management strategies for
hundreds of diseases and conditions and for special approaches across the entire population, including special
and vulnerable populations of all ages. The KL2 program seeks support for an educational curriculum designed
to meet the special needs of emerging, talented investigators across all disciplines. This program is designed
to adapt to the individual needs of each scholar and build upon and improve the CTSC's existing highly
successful program to address unmet educational and career development needs of clinical research scholars
of all professions in the rapidly evolving field of C/T science. Unmet needs will be addressed by educating
leaders in multidisciplinary clinical and translational research, introducing clinical research education earlier in
the life cycle of scholars from diverse disciplines (nursing, bioinformatics, social work, engineering,
pharmacology, psychology, etc.), tailoring programs to the preferences, special interests, research plans,
strengths, and weaknesses of each scholar with appropriate modifications, as required, for each discipline, and
setting the standards and developing innovative approaches to C/T career development. The program builds
on lessons learned from prior experience in operating a highly successful KL2 program, proven strategies from
published national studies on mentorship, collaboration with other CTSA Hub KL2 sites, new and innovative
programs to re-enforce the strengths of scholars in a broad and deep spectrum of capabilities, and a robust
education and career development program that utilizes all resources within the CTSC and synergizes with the
TL1 pre-doctoral and postdoctoral programs. The KL2 Career Development program aims to 1) further enrich
and expand integrated CTSC-wide innovative and individually tailored KL2 program, 2) prepare the next
generation of investigators with the multidisciplinary skills required to lead cutting-edge C/T research and meet
the opportunities and challenges of medicine in the 21st Century, and 3) build the multidisciplinary workforce of
the future. The highly adaptive KL2 program focuses on addressing the individual gaps in knowledge and skill
of each scholar. The current program benefits from a cross-institutional, cross-disciplinary C/T research career
development program, which, in turn, derived from the successful introduction of the Roadmap K12
multidisciplinary C/T research program launched in 2004. As the program was re-designed, best practices
were kept from earlier iterations, what was learned from scholar feedback was incorporated, available
institutional resources carefully considered, and attention paid to desired outcomes (what was accomplished
and who was reached), results (short, intermediate and long term), published literature and the overall impact
of the entire program.